Small-Molecule Pharmacological Chaperones to Prevent Synuclein Transmission

? DESCRIPTION (provided by applicant): Our overall goal is to discover small molecule chaperones targeting α-synuclein (αSyn) that prevent the prion-like transmission of misfolded αSyn and can be developed into drugs to treat neurodegenerative diseases such as Parkinson's (PD), Diffuse Lewy Body, and Alzheimer's diseases. These drugs will act via a novel mechanism of action by directly interacting with αSyn to prevent spreading of αSyn in the brain, with the ultimate goal of reducing disease progression. We envision an innovative strategy by which small molecules bind to and stabilize native or other non-pathogenic states of αSyn and thereby block pathological events. Most small molecules affecting αSyn aggregation were found in aggregation assays and interact with aggregation pathway forms of αSyn. By contrast, we will test compounds that bind to αSyn native states and affect αSyn dysfunction more broadly. From a biophysical screen we previously identified 61 compounds that bind to native αSyn (αSyn-PCs) some of which prevented αSyn-mediated dysfunctions such as αSyn aggregation and αSyn-induced vesicular dysfunction. Based on these promising results, we propose to expand the development of αSyn-PCs as novel αSyn chaperone drugs. In this application, we will determine if αSyn-PCs are a viable strategy to limit αSyn cell-to-cell transmission and explore the mechanism of action of such active compounds. We will first identify αSyn-PCs capable of preventing the cell-to-cell transmission of αSyn and in so doing, identify molecules having potential to be developed into therapeutic drugs. In Aim 1 we will screen the αSyn-PCs in cellular assays of αSyn transmission including a FRET-based assay in which transmission is measured as a direct association of donor αSyn with acceptor αSyn expressed in different cells. Based on preliminary data we expect to find active compounds. Structure activity relationships will be explored by testing activity of commercially available analogues of active compounds. In Aim 2 we will further identify which steps of transmission are modulated by different αSyn-PCs. Different compounds will likely affect αSyn transmission by different mechanisms (e.g., altered cellular levels, location, expulsion, uptake, misfolding) and thus novel mechanisms are likely to be identified using αSyn-PCs. It will be greatly informative for further therapeutic optimization to explore these novel mechanisms. We will analyze the active αSyn-PCs to identify which stage in transmission is blocked. Biochemical, microscopic and cell biological techniques will be applied to explore the cellular and extracellular location and state of αSyn in media and donor and recipient cells. These analyses will elucidate how active αSyn-PCs modulate the transmission of αSyn and will shed light on possible assays that would be useful for future development of these molecules into drugs to treat patients. These studies will provide the first evidence for efficacy of αSyn chaperones in blocking the transmission of a critical protein involved in PD progression and pathology and will provide the foundation for the development of a novel class of drugs for treating αSyn related neurodegenerative diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: The overall goal of this research project is to find therapeutic drugs for neurodegenerative diseases associated with the protein -Synuclein such as Parkinson's disease, Alzheimer's disease, and Diffuse Lewy Body disease. Our novel approach is to find small molecules that "chaperone" -Synuclein to prevent its spreading, aggregation and toxicity in these diseases. This grant proposes to find such small molecules in cellular and animal models of disease as a first step in developing therapeutic drugs based on this approach.